Center for Gastrointestinal Biology and Disease

PROJECT SUMMARY
The burden of gastrointestinal, liver and pancreatic diseases in the US exceeds $135 billion. The overall
mission of the Center for Gastrointestinal Biology and Disease (CGIBD) is to promote multidisciplinary
research to reduce the burden of digestive diseases. The Center achieves this mission through the following:
1) Core facilities that provide new technologies, expertise, training, technical assistance, laboratory animals,
biostatistical and clinical research support. 2) A pilot/feasibility program that provides startup funds to
promising investigators. 3) A scientific enrichment program consisting of seminars, special lectures, workshops
and competitions for trainees that improve the intellectual climate for gastrointestinal biological research. 4) A
professional development and training program that fosters the careers of junior faculty and trainees. Members
of the CGIBD are basic and clinical scientists from diverse disciplines dedicated to advancing our
understanding of the biology, physiology and epidemiology of digestive diseases. The overarching theme for
the Center is Homeostasis, Injury and Repair, a theme that encompasses the wide range of digestive disease
research conducted by the membership. Within the theme, members cluster into three areas of research focus:
microbiome, clinical/translational research, regenerative medicine/repair. The research base includes 47 full
members and 9 associate members from 22 departments. The annual direct costs for digestive disease-related
grants to members total $27.9 million. To support the research of members, the Center proposes an
Administrative Core to organize the activities of the Center and the following scientific cores: 1) Advanced
Analytics; 2) Biostatistics and Clinical Research; 3) Gnotobiotic Animal; 4) Large Animal Models. These cores
have evolved to support the scientific directions of center members and to provide new investigative
opportunities. The cores improve efficiency, lower cost, and provide services that would not otherwise be
available to investigators. Through all of its activities, the Center improves communication, promotes
collaboration, develops careers, and generally enriches the environment for digestive disease research.

Public health relevance
PROJECT NARRATIVE The annual burden of digestive diseases is considerable, exceeding $135 billion. The Center for Gastrointestinal Biology and Disease promotes multidisciplinary research to improve the understanding of the biology, physiology and epidemiology of digestive diseases. The expectation is that this knowledge will be translated into new strategies for prevention and treatment that will lower the burden of digestive diseases.